The Immunobiology of Heparin-Induced Thrombocytopenia

ABSTRACT
Heparin-induced thrombocytopenia (HIT) is an immune reaction caused by antibodies (Abs) that target platelet
factor 4 (PF4) when bound to heparin (H) or other glycosaminoglycan-like polyanionic molecules. HIT usually
results in a low platelet count, but is too often associated with devastating venous and/or arterial thrombosis and
thromboembolism. While many heparin-exposed patients test positive for the presence of PF4-binding Abs, only
those with HIT have "pathogenic" Abs that activate platelets. The complexity of current diagnostic tests limits
their value for timely treatment decisions, which can lead to over-diagnosis of HIT. While failure to diagnose HIT
creates a significant risk of catastrophic thrombosis, equally concerning is that an erroneous diagnosis of HIT
not only prolongs hospital stay and increases costs, but also needlessly exposes a patient to treatments with
potentially serious side effects. Hence, there is an urgent need for a rapid and precise diagnostic test for HIT.
The molecular basis for the crucial functional differences between the PF4/H-binding Abs that are platelet
activating (PA) from those that are not (NA) is unknown, however, and hinders this effort. Furthermore, the
absence of monoclonal (m) Abs from actual HIT patients has also hampered our ability to dissect the
pathogenesis of HIT. We have recently achieved a breakthrough in this regard by successfully cloning 54 IgG1+
PF4/H-binding mAbs from HIT patients. Among these clones, seven demonstrated platelet-activating properties.
Notably, although the PF4/H-binding capability of both PA and NA mAbs was found to be similar, only the PA
mAbs physically bound to PF4-coated platelets. Specific Aim 1 seeks to build upon these novel findings by
further characterizing the molecular and structural biological interactions underlying the binding of platelet-
activating HIT Abs to PF4 on the surface of platelets. A thematically related subject to be addressed in Project 2
deals with the etiology of HIT, and builds on our recent observations that pre-existing B cells that produce basal
levels of PF4/H-reactive IgM Abs are constitutively present in both humans and mice. It remains unknown,
however, how these pre-existing PF4/H-specific Abs and B cells are generated, or how they might contribute to
the development of HIT. Studies in germ-free mice have linked gut microbiota to the presence of naturally
occurring PF4/H-reactive IgMs and PF4/H-specific IgGs. Specific Aim 2, therefore, will identify the specific gut
microbial species associated with the selection and development of PF4/H-specific B cells that predispose
individuals to later development of HIT. Taken together, developing a more complete understanding of the
interactions between HIT PA Abs and platelet surface antigens, coupled with elucidating the role of gut microbiota
in generating these Abs, will provide novel insights into the pathogenesis of HIT, with significant implications for
diagnosing, preventing, and treating this severe acquired clinical disorder. Proposed studies will leverage shared
Core resources, with added benefits from parallel concepts and ongoing collaboration among Project and Core
leaders within this cohesive Program Project.

Public health relevance
NARRATIVE Heparin-induced thrombocytopenia (HIT) is an adverse immune reaction resulting from antibodies targeting platelet factor 4 (PF4) bound to heparin, causing morbidity and mortality in patients undergoing heparin treatment. This research characterizes the interactions between HIT antibodies and PF4/heparin complexes, as well as identifies gut microbiota species associated with the generation of HIT antibodies. These findings will offer new insights into the pathogenesis of HIT, impacting its diagnosis, prevention, and treatment.